COMPARISON OF 2',3'DIDEOXYINOSINE AND ZIDOVUDINE IN PATIENTS WITH AIDS OR ARC

This study compares the efficacy and toxicity of orally administered ddI with orally administered ZDV in the treatment of patients with symptomatic HIV infection and AIDS.